Vaccine Immunology Program

The Vaccine Immunology Program is responsible for the end point analyses of clinical vaccine, antibody therapeutic and prevention trials carried out by the Vaccine Research Center or in collaboration with intramural and extramural investigators. In addition, the VIP investigates basic B cell immunobiology to elucidate the mechanisms that inform the discovery and development of vaccines for public health, including HIV, Influenza, Ebola, Malaria, TB, in addition to other emerging and re-emerging infectious diseases. This involves development of sophisticated and high-throughput analyses that supports in-depth investigation of clinical trials, including highly qualified clinical assays for use in pre-clinical evaluation, IND submissions, for product licensure, and to evaluate trial endpoints.